Los Angeles - Southern California (LASC) NIH StrokeNet Regional Coordinating Center

Project Summary/Abstract
Stroke is the 4th leading cause of death and a leading cause of disability in Southern California. It is imperative that new treatments for stroke prevention, acute therapy, and recovery be efficiently developed. This application is to renew the NIH Los Angeles – Southern California Stroke Net Regional Coordinating Center (LASC Stroke Net RCC) that marshals a network of 43 acute stroke and rehabilitation medical centers in Los Angeles and Orange Counties, Sacramento, and New Mexico, which will perform 5-15 NIH Stroke Net trials in prevention, acute, and recovery, efficiently and excellently. Participating hospitals in the network include 7 academic and 34 mixed academic-community and community medical centers. The four specific aims of this proposal are to: 1) perform high quality NIH Stroke Net acute and prevention trials throughout Los Angeles and Orange Counties, Sacramento, and New Mexico; 2) perform high quality NIH Stroke Net recovery and rehabilitation trials throughout Los Angeles and Orange Counties, Sacramento, and New Mexico; 3) ensure participation of high volumes of underserved populations in NIH Stroke Net trials, including women, Hispanic-American, African-American, and other minority populations; and 4) provide an educational environment that stimulates fellows, research study coordinators and program managers, residents, medical students, premedical students, and junior faculty to engage in stroke translational research.

Public health relevance
Project Narrative Stroke is the leading cause of combined death and severe disability in the United States. It is imperative that new treatments for stroke prevention, acute therapy, and recovery be efficiently developed. This application is to renew a large-scale regional clinical trial network to accelerate testing and validation of promising new stroke preventive, acute, and reparative therapies.